Data Management Core

PROJECT SUMMARY/ABSTRACT
Data Management Core
The Data Management Core serves as the central location for quantitative and qualitative data management,
data analysis, and data sharing for the proposed Learning Disabilities Research Center (LDRC), Learning
Disabilities Translational Science Collective: Building on the Florida LDRC. To support the center, the Data
Management Core has three specific aims. Aim 1: To provide leadership, services, and flexible systems for
data collection and management for all projects. Aim 2 is to provide guidance on research design and
statistical analysis to each of the core projects. Aim 3 to provide expertise and assistance to share data
resulting from the projects. In addition, in Aim 4, we will support the center as well as the broader research
community by developing products and trainings to provide career enhancement efforts for early career
scholars.